Decoding human T-cell allospecificity

Summary
CD8+ T cells are the main drivers of acute cellular rejection (ACR) of transplanted tissues. While T cells can
recognize alloantigens directly (through direct responses to allo-HLA) as well as indirectly (through allopeptides
bound to self-HLA), the major consensus is that direct recognition plays a major role in ACR. However, much is
unknown about the biology of T cells responsible for direct ACR. For decades, alloreactive T cells have been
viewed as either responding primarily to unique determinants on allo-HLA (HLA-centric responses), or to a
plethora of non-self peptides presented by allo-HLA (peptide-centric). Recent data though has suggested that
many alloreactive T cells are allospecific, responding to unique peptide/allo-MHC complexes present on the
surface of allografts. Moreover, additional data suggests that alloreactive T cells may share reactivities with
immunodominant viral epitopes and may in fact derive from pre-existing memory pools. While there is growing
clarity around the structural features and immunological origins of alloreactive T cells, the lack of knowledge
regarding the specificities of alloreactive T cells is a major reason for our limited biologic insight into T cell-
mediated ACR. We are now poised to make a substantial breakthrough in this area and capitalize on it to better
understand ACR and alloreactivity in general. In initial studies, using scRNA sequencing on biopsies and urine
from several patients undergoing kidney transplant rejection, we found a remarkably and unexpectedly small
number (~10-20/patient) of clonally expanded T cells with unique TCR CDR3 a/b sequences, and have
confirmed their specificity towards the transplanted tissue. These expanded T cell clones persist for months in
rejecting allografts, despite traditional anti-rejection therapy. The goal of this ambitious, high risk/high reward
project is to identify the ligands recognized by alloreactive T cells within transplant biopsies, including both
alloantigens and any cross-reactive viral epitopes and use this knowledge to begin decoding the immunobiology
of ACR, identify possible therapeutic targets, and expand our understanding of the nature and origins of
alloreactivity. Our specific hypotheses are that (i) the majority of clonally expanded allospecific TCRs recognize
unique tissue restricted peptides presented by allo-HLA; (ii) many of these TCRs are also cross-reactive with
viral epitopes presented by self-HLA; and (iii) identification of peptide targets will enable us to decode the
transcriptomes of allospecific T cells in kidney allografts. Success in this multi-PI R21 proposal will pave the way
for numerous, deeper, groundbreaking studies of alloreactivity, graft rejection, and novel therapeutic modulation
of ACR.

Public health relevance
Project Narrative This project will study the immunological underpinnings and origins of alloreactivity and acute cellular rejection of transplanted tissues. Success here will help advance our understanding of rejection and set the stage for advances in treatment and prevention.